Astrocyte-microglial communication in developmental synapse formation

PROJECT SUMMARY/ ABSTRACT
Regulation of synapse homeostasis is essential for normal brain development and function, and intimately
dependent on astrocytes and microglia -- the support cells of the brain. Astrocytes contact thousands of
synapses and promote developmental synapse formation. Microglia are brain-resident immune cells
increasingly implicated in both synapse formation and pruning. We have discovered a novel signaling circuit
between astrocytes and microglia that promotes synapse elimination in the developing central nervous system
(CNS). We found that astrocytes express the immune signal Interleukin-33 (IL-33) whereas microglia express
the IL-33 receptor (IL1RL1.) We subsequently showed that in the spinal cord, eliminating IL-33 from
developing astrocytes leads to excess synapses, and that IL-33 signals to microglia to drive synapse
engulfment and lead to synapse depletion. Our central hypothesis is that astrocytes express and release
IL-33 in response to neuron-derived signals, and that IL-33 in turn drives microglial synapse
elimination. We will test this hypothesis in three distinct but interrelated aims, focusing on a well-defined and
experimentally accessible circuit in the ventrobasal sensory thalamus (VB), where IL-33 is highly expressed
during synapse refinement. In Aim One we will determine how astrocytic IL-33 regulates thalamic synapse
subtypes and circuit function. We previously showed that global deletion of IL-33 lead to hyperexcitability of the
VB circuit and excess synapses. Here we will conditionally delete IL-33 from astrocytes and explore these
phenotypes in more detail, quantifying subtypes of afferent excitatory and inhibitory synapses to understand
how different components of the circuit are altered. In Aim Two, we will determine the molecular mechanisms
regulating microglial synapse engulfment. We previously found that IL-33 promotes engulfment of postsynaptic
proteins by microglia. Here, using both standard and high resolution techniques (expansion microscopy), we
will quantify engulfment of both pre- and postsynaptic excitatory elements, as well as inhibitory synapses. We
will test the requirement for direct signaling to microglia via conditional deletion of its receptor. In Aim 3, we will
identify neuronal molecules that induce astrocyte expression and release of IL-33. Our preliminary data
demonstrates that norepinephrine is a neuron-derived cue that promotes expression of IL-33 in gray matter
astrocytes. Here we will further test which noradrenergic receptors on astrocytes mediate this effect in vivo. We
will also test the hypothesis that extracellular release of IL-33 is dependent on neuronal synaptic activity, by
modulating activity in vitro and in vivo. Together, these three aims explore the role of a novel glial-neuronal
circuit mediating synapse homeostasis. We predict that a broader understanding of how glia communicate via
immune molecules to regulate synapses will fundamentally impact our understanding of how neural circuits
change in learning and development as well as in neurodevelopmental diseases.

Public health relevance
PROJECT NARRATIVE Glial cells are the primary support cells of the brain and are critically important for normal brain development. In this proposal, we investigate how two types of glial cells- astrocytes and microglia- communicate with each other via an immune molecule called Interleukin-33 to help brain cells form proper connections. .